Neural mechanisms by which chronic stress regulates inflammation in asthma

DESCRIPTION (provided by applicant): Asthma is a chronic inflammatory disease that poses a significant public health problem affecting approximately 13% of U.S. adults. Individuals with asthma have a two-fold higher risk of developing a mood or anxiety disorder than those without asthma and this co-morbidity is associated with poorer asthma control, increased symptom frequency, and more physician and emergency room visits. Yet research directed at understanding asthma pathophysiology and treatment has neglected the role of the brain almost entirely. The proposed research, therefore, will examine the neural underpinnings of the influence of psychological factors on asthma-relevant physiology. The primary objectives of these projects are to (1) elucidate the neural circuitry through which chronic psychosocial stress influences the inflammatory response in asthma (2) quantify the impact of chronic stress on objective measures of lung function and inflammation and (3) evaluate the impact of neural changes, accrued through training in mindfulness, to alter the impact of chronic stress on the development of airway inflammation. To accomplish these objectives, asthmatic individuals with and without significant chronic life stress, as well as healthy non-asthmatic controls with and without chronic life stress, will be recruited for study. All participants will perform a psychosocial stress test. Positron emission tomography (PET) will be used to measure the neural response to the stressor, such that uptake of radiolabeled glucose will take place during performance of the stress task. PET data (glucose metabolic rate) collected after completion of the task will reflect the relative neural activity that occurred during task performance. Glucose metabolic rate will be examined in relation to measures of lung function (FEV1), inflammation (sputum and blood eosinophils, exhaled nitric oxide), sensitivity of immune cells to inhibition by glucocorticoids, stress responsivity (salivary cortisol and alpha amylase), self-reported asthma symptom control, and self-reported psychological factors (e.g. depression and anxiety). Differences in stress-induced glucose metabolic rate in high versus low chronically stressed asthmatics and controls will be characterized. In addition, the peripheral physiological measures will be examined on their own, and in relation to changes in glucose metabolic rate, to quantify the impact of chronic stress on physiological measures of import to asthma. These data will provide the basis for a subsequent intervention study that addresses objective 3. Training in mindfulness meditation will be evaluated for its ability to impact the effects of chronic stress on the factors that underlie asthma symptom expression. The protocol described above will be employed before participants receive mindfulness training and again following completion of training, in order to examine changes that may occur in the neural response to stress that underlie potential symptom alleviation associated with mindfulness training. The immediate goal of the candidate, Dr. Melissa Rosenkranz, is to understand the neural mechanisms through which chronic stress regulates inflammatory processes in asthma and through which the pathophysiology of asthma promotes mood and anxiety disorders. Her long-term goal is to generalize this aim; to bring to light the mechanisms and pathways through which mental events lead to disease expression and progression, and through which peripheral disease expression causes cognitive and emotional changes. By extension, Melissa hopes to contribute to new ways of approaching healthcare and management of disease, where the brain is featured prominently. Melissa is uniquely situated to successfully carry out the proposed research and to realize these goals. She has already demonstrated her ability to execute highly complex and collaborative research projects of this nature, as is evident in her strong publication record. Nonetheless, interdisciplinary research poses a significant challenge to young scientists. To pursue these goals with the utmost rigor requires expertise in not one, but at least three distinct methodological domains: psychology, neuroscience, and immunology. Typically, a student would spend several years becoming an expert in any one of these domains. Thus far, her training has focused primarily on methods in the first two. A career development award will provide the protected time, resources, and formal structure for Melissa to greatly expand her expertise in immunology and neuroanatomy via formal mentorship and advisory relationships, and to add a new neuroimaging modality (PET) to her repertoire of tools. In addition, she will receive training in and support for a key component of her long-term goal: to determine how changing neural function, through mental training techniques, impacts the relationship between psychological events and disease expression. Melissa's sponsor, Dr. Richard Davidson, and co-sponsor, Dr. William Busse offer unparalleled expertise, training opportunities, and resources with which Melissa can flourish as a young investigator in addressing questions of significant public health importance. Her questions are tractable and her research resubmission and training objectives are bold and innovative. The combination of expertise that she brings to this opportunity and the expertise and resources that her team of mentors and advisors can impart to her creates an ideal scenario for Melissa to make substantial contributions to this field.

Public health relevance
Project Narrative Asthma is a chronic disease that affects nearly 13% of adults in the U.S., causing substantial impairment that is reflected in the tens of millions of missed days of work, and doctors' and emergency room visits it leads to annually. Those who have asthma are twice as likely to develop depression and anxiety, which are associated with more frequent and severe asthma symptoms, especially in those under chronic stress. The project proposed here seeks to understand the role of the brain in these associations and to evaluate the neural mechanisms through which a safe, low-cost intervention, that influences the function of body via the mind, may diminish the expression of asthma symptoms. __SpecificAimsTextDelimiter__ Statement of Hypotheses and Specific Aims This program of research is designed to determine the mechanisms by which chronic stress regulates the development of the inflammatory response in asthma. From the models that we have developed, we hypothesize that an acute stress stimulus that is superimposed on a background of chronic stress will lead to increased expression of inflammatory markers in asthmatic individuals, and that increased activation in neural circuits involved in processing and responding to emotional information will predict this change. Decades of research suggests that psychosocial stress and emotion may exacerbate, and perhaps prime, symptom expression in asthma. Similarly, inflammatory mediators involved in an asthma exacerbation have been shown to act on the brain, leading to multiple effects including anxiety and deterioration of mood. Indeed, a recent feature in the Journal of the American Medical Association (Kuehn, 2008) reports that individuals with asthma have a two-fold higher risk of having one or more anxiety or depressive disorders. Despite the compelling evidence that psychological events significantly contribute to asthma morbidity, research aimed at understanding its biological underpinnings and management has focused almost exclusively on the periphery. Therefore, this research proposal addresses (1) the role of emotional neural circuitry in processing and modulating asthma symptom expression and (2) the impact of an intervention aimed at altering cognitive and emotional processes on the expression of asthma-relevant markers in asthmatics. In the Study 1 (specific aims 1 & 2), four groups of subjects will be recruited and comprised of chronically stressed and non-stressed individuals with and without allergic asthma; each will then undergo a standardized psychosocial stressor - the Trier Social Stress Test (TSST). We will then evaluate the response to this stress stimulus by measurement outcomes including symptoms, lung function, measures of pulmonary inflammation, and imaging of the lungs and brain to define organ involvement. We have demonstrated the feasibility of both the neuroimaging component (Kern et al., 2008) and the peripheral asthma outcome measures (Rosenkranz et al., 2005) in previous studies. Objective measures of pulmonary inflammation will include exhaled nitric oxide (NO) and inflammatory cell differentials (e.g. eosinophils) measured in blood and sputum. Lung function will be assessed using spirometry. Salivary levels of cortisol and alpha amylase will provide an index of the magnitude of the physiological response to the stressor. These routine measures will then be compared to changes in neural activity during the TSST measured using [F18]fluoro-deoxyglucose positron emission tomography (FDG-PET). Radiolabeled glucose (FDG) will be injected prior to the TSST and uptake into the brain will occur during performance of the stress test, outside of the scanner. After completion of the TSST, regional levels of FDG, detected using PET, will reflect the relative neural activity during the TSST performance. Moreover, FDG uptake into the airways will provide an additional measure of airway inflammation (Taylor et al., 1996). PET methodology is well-suited for this design because it integrates changes in neural activity that take place over an extended period of time and, more importantly, allows for the social interaction that is essential for eliciting a strong acute stress response. This study will be carried out in Years 1 & 2 or the award period. In Study 2 (specific aims 3, 4 & 5), this design will be employed pre- and post-participation in mindfulness-based stress reduction (MBSR) training. MBSR training consists of continuous focused attention on the breath, bodily sensations and mental content while in seated postures, walking, and doing yoga. It is the dominant form of meditation training in medical settings in the U.S., and since its inception in 1979, has shown benefit in alleviating symptoms of a broad array of conditions from anxiety disorders to diabetes. Instruction will be delivered over 8 consecutive weeks by an experienced and certified instructor. This study will be carried out during Years 3-5 of the award period. Specific Aim 1 (study 1): Determine the impact of chronic stress on inflammatory processes in asthmatic individuals. Hypothesis: An acute stressful event will provoke an increase in inflammatory markers in chronically stressed asthmatics and a decrease in inflammatory markers in non-stressed asthmatics. Further, the degree of stress reactivity, as measured by salivary cortisol and alpha amylase, will predict changes in inflammatory indices. Neither group of controls should show changes in these asthma-specific markers. Specific Aim 2 (study 1): Determine the neural circuitry underlying the inflammation-promoting effects of a psychosocial stressor (TSST) in chronically stressed asthmatics using PET-FDG. Hypothesis: Based on our previous research, we predict that activity in the insula and anterior cingulate cortex (ACC) during the TSST will be elevated in chronically stressed asthmatics and will predict levels of inflammatory markers that lead to asthma symptoms. We expect the circuitry engaged by the TSST to partially overlap between chronically stressed and non-stressed participants, however the glucose metabolic rate in the insula and ACC will differentiate these groups. Specific Aim 3 (study 2): Investigate the changes in the neural responsivity to acute stress that result from MBSR training. Hypothesis: Insula and ACC activity during the TSST will be reduced following MBSR training, relative to pre-training. Specific Aim 4 (study 2): Determine the impact of mindfulness-based stress reduction training on inflammatory markers in chronically stressed individuals with asthma. Hypothesis: the potentiating effects of acute psychosocial stress, combined with chronic stress, on asthma symptoms will be reduced following MBSR training. Moreover, the amount of time spent practicing MBSR will predict the reduction in inflammatory indices. Specific Aim 5 (study 2): Determine the interaction between the neural changes and changes in inflammatory markers, in response to acute stress, brought about by training in mindfulness-based stress reduction. Hypothesis: The degree of change in activity in the insula and ACC will predict the change in inflammation, from pre- to post-MBSR training, expected in chronically stressed asthmatics. In the service of career development, this proposal also contains a comprehensive training plan comprised of the following aims: Training Aim 1: In-depth training in PET imaging, including the physics of PET imaging, operation of the PET scanner, designing and implementing a PET protocol, and collecting, processing, and analyzing PET data. Training Aim 2: Comprehensive training in immunological methods and asthma immunology, including performance of assay techniques relevant to the proposed research, regular attendance at professional asthma meetings followed by discussion of presentations, education in the molecular mechanisms through which stress impacts the immune system, particularly as it pertains to the inhibitory functions of glucocorticoids on cells of the immune system. Training Aim 3: Training in neuroanatomy, with a focus on circuitry relevant to interoception and communication between the brain and the immune system. This training will also involve discussions pertaining to the influence of emotion and other psychological states on this circuitry. Training Aim 4: Training in the scientific study of meditation, including yearly attendance at the Mind & Life Summer Research Institute, participation in meetings with contemplative experts and high level scientists in the context of the activities of the Center for Investigating Healthy Minds, and participation in the activities of the NCCAM Center. Also involved in this training will be guidance and education regarding how meditation may impact specific factors that contribute to the stress response. Training Aim 5: Professional development and leadership training.